Locus coeruelus-prefrontal interactions for flexible decision-making

PROJECT SUMMARY/ABSTRACT
Higher brain functions include the ability to learn expectations about the world, update those expectations
appropriately when given new sensory information, and use those continually updating expectations to guide
behavior. How neural circuits implement these flexible information-processing dynamics is not known. We
propose a novel research project that, consistent with the goals of the BRAIN initiative, uses innovative,
methodologically integrated approaches to understand how activity pattens in a specific circuit in the primate
brain support flexible updating used for behaviorally relevant decisions. The circuit includes two main
components with known properties relevant to our proposed studies. The first component is the dorsolateral
prefrontal cortex (dlPFC), which includes neurons that encode ongoing processing of expectations and sensory
evidence in working memory. The second component is the locus coeruleus (LC)-norepinephrine (NE)
neuromodulatory system, which can affect working-memory representations in the dlPFC. However, it is not
known whether and how LC-NE modulations of working-memory representations in dlPFC contribute to flexible
decision-making. Building on our previous work on flexible decision-making and effects of the LC-NE system
on neural information processing, we propose and test the hypothesis that LC-mediated NE release in dlPFC
governs how dlPFC neural populations flexibly combine learned expectations held in working memory with
incoming sensory information to form decisions that guide behavior. We test this hypothesis by training
monkeys on a novel task that allows us to quantify how learned expectations and new sensory information are
combined in a flexible, context-dependent manner to make saccadic decisions. We then elucidate the
underlying circuit mechanisms, via three Aims that each leverage an innovative set of approaches. Aim 1 is to
measure how LC and dlPFC activity at a single-neuron resolution relates to flexible decision-making. Aim 2
uses multiple techniques, including electrical microstimulation for temporal specificity and chemogenetics for
pathway specificity, to test for causal roles of temporally specific firing patterns of LC->dlPFC projections on
flexible decision-making. Aim 3 uses computational modeling to relate LC-dlPFC circuit properties (including
NE-mediated changes in neuronal gain) to computational principles that support flexible decision-making. Each
Aim alone provides new insights into correlative, causal, and computational contributions of the LC-dlPFC
circuit to flexible decision-making. Taken together, these studies provide a novel, unified view of how the LC-
PFC circuit performs critical computations that flexibly combine expectations with evidence to inform decisions.

Public health relevance
PROJECT NARRATIVE The proposed work is basic research, designed to generate new insights into how a circuit involving the brainstem nucleus locus coeruleus and the prefrontal cortex contributes to flexible decision-making in the healthy primate brain. Thus, direct benefits to public health would occur in the longer term, as these new insights can be applied to design new ways to diagnose and treat disorders with cognitive deficits that involve abnormalities in this circuit (e.g., schizophrenia and depression).